Defining the roles of small KH-domain RNA binding proteins in mycobacteria

Project summary
Mycobacteria include important human pathogens such as Mycobacterium tuberculosis, and
elucidating the mechanisms by which they regulate gene expression is necessary to understand
their mechanisms of surviving drugs and other stressors encountered during infection. However,
the mycobacteria are evolutionarily divergent from better-studied model organisms. Small RNA
binding proteins have critical roles in mediating sRNA-mRNA interactions and modulating mRNA
stability in E. coli. However, mycobacteria lack orthologs of the RNA binding proteins that are
best characterized in E. coli. Instead, mycobacteria encode two putative RNA binding proteins,
KhpA and KhpB, that have orthologs in some gram-positive bacteria where their functions are
poorly understood. Given the almost complete absence of published data on small RNA binding
proteins in mycobacteria, we propose to determine the biochemical properties and functional
impact of KhpA and KhpB using the non-pathogenic model mycobacterial species
Mycolicibacterium smegmatis. The proposed project will address a major knowledge gap in the
mycobacterial field while providing in-depth training opportunities for undergraduate students at
Worcester Polytechnic Institute. We hypothesize that KhpA and KhpB form both homodimers
and heterodimers that bind differing suites of mRNAs and small regulatory RNAs (sRNAs),
affecting their stability and function. The objectives of this proposal are to determine the
functional oligomerization states of these two proteins; determine the compendia of RNAs that
they bind; identify the properties that make these RNAs targets of KhpA/B; determine the impact
of khpA/B on RNA degradation rates; and determine the impact of khpA/B on growth and stress
tolerance.

Public health relevance
Project narrative The mycobacteria are a group of bacteria that includes several important human pathogens that cause difficult-to-treat diseases. Understanding the fundamental biology of these bacteria is important for developing better treatments. The goal of this project is to understand the roles of two proteins that are important for mycobacterial growth but have not been previously studied.